The role of the subacromial bursa in rotator cuff degeneration and healing

ABSTRACT
Rotator cuff degeneration results in shoulder pain and disability and a high incidence of rotator cuff tears. More
than half of the population over the age of 65 has a rotator cuff tear, leading to ~600,000 surgical repairs each
year in the United States. Unfortunately, the failure rates after surgical repair are unacceptably high, particularly
in the older patient population with large tears. This project focuses on the subacromial bursa, a synovial-like
tissue in the shoulder that is situated between the acromion and the rotator cuff tendons. This tissue was
previously thought to function as a mechanical cushion and low friction gliding surface to protect the underlying
tendons. The belief that the bursa is biologically inert motivated the current clinical standard of surgically
removing the bursa in many scenarios. Contrary to this practice, our global hypothesis is that the subacromial
bursa is a critical paracrine regulator of shoulder health with important roles in rotator cuff pathology and healing.
Furthermore, due to its location above the rotator cuff, the bursa is an ideal therapeutic target for modulating
rotator cuff degeneration and enhancing repair. In Aim 1, the role of the subacromial bursa in rotator cuff tendon
degeneration and healing will be examined. We hypothesize that bursectomy will exacerbate rotator cuff
degeneration of intact tendons and impair healing in models of rotator cuff tendinopathy. In Aim 2, patterns of
cellular crosstalk between the subacromial bursa and the rotator cuff will be interrogated. We hypothesize that
rotator cuff tendinopathy will activate the bursa through paracrine signaling, leading to recruitment of
inflammatory cells and expansion of resident mesenchymal stem cells in the bursa. In Aim 3, the therapeutic
potential of targeting the subacromial bursa for improving rotator cuff healing will be determined. We hypothesize
that inhibition of inflammatory signaling in the bursa will shift bursa-derived paracrine factors from inflammation-
dominant to regeneration-dominant, leading to enhanced rotator cuff healing. The project will lead to novel bursa-
targeted pharmacologic therapies for rotator cuff repair, addressing the pressing clinical need to improve
outcomes after rotator cuff repair.

Public health relevance
NARRATIVE Rotator cuff disease is a significant clinical problem affecting millions of individuals each year. Rotator cuff tears require repair of tendon to bone, yet successful healing is rarely achieved. Our aim is to translate our recent discoveries on the role of the bursa in rotator cuff healing into treatments for improving outcomes after rotator cuff repair.